Functional Microbiomics, Inflammation and Pathogenicity

Abstract
The primary objective of the Functional Microbiomics, Inflammation, and Pathogenicity (FMIP) CoBRE at the
University of Louisville (UofL) is to establish a comprehensive and interdisciplinary research center focused on
exploring the intricate relationship between the microbiome, inflammation, and pathogenicity. Over the past six
years, we have successfully brought together a group of promising junior investigators, each possessing unique
expertise, and paired them with highly qualified and dedicated mentors. Through a collaborative effort, a cohesive
set of complementary projects has been developed, forging innovative connections between inflammatory
processes and bacterial pathogenicity. This has led to successful graduation of six junior faculty with NIH R01
awards and three of these investigators are still at UofL and are transitioning into mentoring roles while
establishing their own strong scientific programs. These achievements were supported and facilitated by the
Functional Microbiomics Core, which provides essential resources such as germ-free animal facilities, anaerobic
culture capabilities, microbiome sequencing, bioinformatics support, and the assay of inflammatory markers.
For Phase I and II of the FMIP CoBRE we have made significant commitment to expand our microbiomics core
capabilities by developing anerobic culture, germ free, gnotobiotic and advanced imaging facilities. Many of our
RPLs and their mentors are now experiencing a growing need for the capability to swiftly and easily identify and
quantify small molecules, such as host and microbial metabolites from various sources. Here, we propose to
further expand microbiome area into metabolomics by purchasing the TSQ Quantis Triple-Stage Quadrupole
Mass Spectrometer from Thermo Scientific. This mass spectrometer provides reliability and sensitivity and will
be a significant addition to our CoBRE core facility. This supplement application is requesting partial funding from
to acquire and establish the CoBRE-Metabolomics facility at the UofL that focuses on microbial and host
metabolites. This core will support the research of large number of faculty working in the areas of microbiota,
inflammation, and pathogenesis.

Public health relevance
Narrative Host and microbial metabolites play a crucial role in the regulation of inflammation and are linked to the onset of diverse human diseases, such as periodontal disease, inflammatory bowel disease, cancer, and Alzheimer’s disease. This proposal aims to establish a CoBRE-Metabolomics facility under Functional Microbiomics Core by purchasing TSQ Quantis Triple-Stage Quadrupole Mass Spectrometer. This facility will enable identification and quantification of both targeted- and untargeted metabolites across various pathophysiological conditions.